Genomic Characterization and Surveillance of Microbial Threats in West Africa

Project Summary – Overall
Recent viral outbreaks in West Africa, specifically the 2013-16 Ebola Virus Outbreak, shed light
on the many limitations of current surveillance and diagnostics in the region's public health
systems. Tools for rapid, accurate diagnostics and genomic analysis of patient samples were
often not readily available in the areas that were most severely affected by the disease, making it
more difficult to reduce morbidity and mortality during the epidemic. There is a need for Africans
to get more engaged in locally using the wide array of genomic techniques and data in order to
improve patient treatment. . This proposal aims to characterize and survey microbial threats
across West Africa, such as Ebola, Lassa fever, and malaria, by building on a long-term
collaborative effort among established academic, research and clinical centers in Nigeria (RUN,
ISTH), Senegal (UCAD), and Sierra Leone (KGH), along with additional partners in the US at the
Broad Institute and Tulane University. The proposed collaborative center will (1) utilize next
generation sequencing and microbial metagenomics technologies to identify and characterize the
nature and extent of circulating viral pathogens at the study sites; (2) develop robust and cost-
effective field diagnostics, using both molecular and immunoassays to swiftly and accurately
capture the prevalence of these pathogens in the population, and (3) use this genomic and
immunological data, along with studies on the clinical manifestations of these diseases, to
characterize the pathogen-host interaction and enhance clinical care. In addition the proposed
project will substantially increase the building capacity for African scientists in the field of
genomics, both by improving the technical resources at the project sites and through intensive
training in genomics and bioinformatics at both the African and US sites. Specifically, using
Illumina MiSeq instruments currently on site in Nigeria and Senegal (and coming soon to Sierra
Leone), we will further expand capacity for next generation sequencing and computational
analysis.. These activities serve our overall strategic goals of moving more research operations
to African sites and empowering African scientists to perform cutting-edge genomic infectious
disease research and discovery fully within the continent.

Public health relevance
Project Narrative This project aims to enable a more comprehensive understanding of the microbial disease landscape in West Africa and create genomic tools and innovative solutions to combat these devastating infectious diseases. The project will also promote training and capacity building in Africa, maintaining self-sufficiency and sustainability by empowering African scientists and research centers.